USE OF STEPWATCH ACTIVITY MONITOR IN CHILDREN

Two groups of 6 able bodied children from 5-6 years and 8-9 years will be recruited and undergo evaluation using the Step Watch activity monitor. This custom, computerized accelerometer will record total activity and patterns of activity for our subjects over 2 week intervals. Each child will undergo 2 testing periods during different seasons. The data will provide preliminary information regarding a child's primary daytime function, play.